Core B: Program Development

Core B. Program Development (Pilot) Core
PROJECT SUMMARY/ABSTRACT
The Program Development Core (B) supports innovative research in developing areas of aging research
through six key mechanisms: (1) a peer reviewed pilot grant program for both emerging and established
scholars that allows faculty to pursue new and innovative topics; (2) a mentorship program for emerging
scholar pilot recipients to assist them in developing successful applications for extramural funding; (3) a weekly
seminar series in which faculty from other institutions present their recent, innovative research; (4) a monthly
student/postdoc/junior faculty seminar—the Demography of Health and Aging (DOHA) seminar—in which
graduate students and postdoctoral scholars, as well as junior faculty receiving pilot funding, present their
current research at various stages of completion and receive feedback from other students, postdocs, and
faculty; (5) regular statistical programming and methods workshops to bring associates up to speed on
methodological developments and approaches in the field; and (6) ongoing efforts to recruit new associates
interested in engaging in important aging research from across the university into CPHA, coupled with efforts
to recruit new faculty engaged in innovative aging research from outside Duke wherever and however possible.